Mechanisms underlying increased risk of hematological malignancy in sickle cell disease.

PROJECT SUMMARY/ABSTRACT
Sickle cell disease (SCD) affects millions globally and results in recurrent vascular occlusions, chronic organ
damage and early death. While childhood mortality is reduced and patients are surviving to adulthood with
current therapies, an increased risk of hematological malignancy (HM) in SCD is becoming evident. Risk of HM
is higher following gene therapy. Gene therapy involves hematopoietic stem cell transplant (HCT) of gene-
modified autologous/sickle hematopoietic stem and progenitor cells (HSPC), and has had remarkable success
and FDA approval. A similar high risk is observed in allogeneic-HCT SCD patients with suboptimal engraftment.
However, the specific pathobiology that predisposes to increased HM is unknown, and necessary to address,
since curative therapies (gene therapy and HCT) are on the forefront. We hypothesize that increased oxidative
stress induced DNA damage results in HSPC clones with deleterious mutations; these clones amplify due to
persistent HSPC replicative stress from SCD, and when the replicative stress is further magnified in gene
therapy, where autologous gene-modified HSPC have to regenerate to reconstitute the entire hematopoiesis
following myeloablative conditioning. We will: (1) Perform gain and loss of function experiments to increase or
reduce the oxidative stress-induced DNA damage to HSPC, and study the development of clonal hematopoiesis
and HM in SCD mice versus their normal counterparts. (2) Impose HCT-mediated regenerative stress on
autologous young and old HSPC and assess whether development of HM occurs de novo, or from existing
clones with deleterious mutations in putative oncogenes by high-depth next generation sequencing. Modeling
the increased risk of HM in SCD will help identify underlying mechanisms, which can then be targeted to mitigate
this risk.

Public health relevance
PROJECT NARRATIVE Sickle cell disease (SCD) is an inherited red blood cell disorder that changes their shapes to bizzare hook/sickle shapes that occlude blood vessels and have shortened lifespan, causing painful events and anemia and contribute to chronic organ damage and mortality. More recently, patients with SCD been observed to have a higher incidence of blood cancers, especially after gene therapy and bone marrow stem cell transplantation. We want to study the underlying mechanism of increased blood cancers in SCD using deep sequencing of leukemia associated genes in bone marrow DNA of SCD mice and normal mice as they age, or when they are transplanted, to model this experimentally and develop targeted therapies.